Axl receptor tyrosine kinase, a potential therapeutic target in glomerulonephritis

Nephritis is a serious complication of lupus and can progress to end-stage kidney failure in patients with active disease. The experiments in this proposal will attempt to increase our understanding the role of Axl receptor tyrosine kinase in regulating kidney inflammation and pathogenesis. Our preliminary data demonstrate that Axl contributes to anti-glomerular base membrane (GBM) antibody-induced nephritis by promoting glomerular mesangial cell survival and proliferation. We have shown that Axl-deficient mice are protected against anti-GBM nephritis and that treatment of mice with R428, a specific small molecule inhibitor of Axl signaling, decreases proteinuria and increases survival in mice with this disease. Based on these observations, we will now investigate the regulation of Axl expression by renal mesangial cells, identify the mechanisms by which Axl signaling promotes the pathogenesis of glomerulonephritis, and determine whether treatment with R428 has a general ability to suppress glomerular disease in mouse models of lupus nephritis. Our studies will be guided by three hypotheses: (1) Axl expression by renal mesangial and tubular cells is upregulated by inflammatory cytokines that act through at least 2 mechanisms: (a) transcription factor binding of the Axl 5'- UTRs; and (b) IL-6 activation of Stat3, which increases Axl transcription by decreasing expression of miR-34a. (2) Axl signaling promotes glomerular disease by acting alone or synergistically with MER and EGFR to increase renal mesangial and tubular survival and proliferation through the PI3K/Akt/mTOR pathway. (3) Axl inhibition by R428 will suppress spontaneous and induced murine glomerular disease. These hypotheses will be tested through three specific aims: 1. Will identify the mechanisms that regulate Axl expression in the inflamed kidney. We will investigate two pathways leading to Axl expression in the kidney: 1) Increased IL-6 in the inflamed kidney leads to STAT3 activation, which increases Axl transcription by inhibiting miR34a expression; 2) Axl transcription in the kidney is driven by multiple transcription factors. 2. Will identify the signaling mechanisms by which Axl promotes glomerulonephritis. We will test the hypotheses that: 1) Axl-induced activation of the PI3K and mTOR signaling pathways promotes the survival and proliferation of mesangial/tubule cells, respectively. 2) Axl synergistically interacts with Mer or the EGFR pathway to activate target cells and stimulate cytokine secretion. 3. Will determine the ability of R428 to suppress the development of glomerulonephritis and treat established glomerulonephritis. We will determine whether R428 can inhibit disease progression prior to and after disease onset in inducible and spontaneous models of nephritis. !

Public health relevance
Nephritis is a serious complication of lupus and can progress to end-stage kidney failure in patients with active disease. Treatments for nephritis are non-specific and hazardous. Upon conclusion, we will understand Axl regulation and activation in inflamed kidney. If our hypothesis is correct, R428, an Axl specific inhibitor, should help to prevent or limit the severity of induced and spontaneous mouse model of lupus nephritis.